Comprehensive Characterization of Breast Tissue Using Multi-modal MRI

ABSTRACT
Diffusion-weighted MRI (DWI) has become a pillar of clinical MRI with its uniqueness to probe tissue
properties well beyond the conventional MRI can achieve with its millimetric resolution. Most DWI applications
rely on apparent diffusion coefficient (ADC) which has been associated with tissue cellularity1,2. However, the
comprehensive properties of tissue cannot be adequately revealed by a single measurement3. Recent
publications indicated these hidden properties can be probed using specific portions of the b-value “spectrum”
in DWI4. For example, intravoxel incoherent motion model5–7 with low-b-values can characterize micro-
vascularity without contrast agent, presenting a potential for complementing dynamic contrast-enhanced MRI
(DCE-MRI)8. High-b-value non-Gaussian models9–24 can probe microstructures as in the case with continuous-
time random walk model17,19,21,25,26 which can reflect tissue micro-structural heterogeneity, thus enable studying
microstructures beyond cellularity and vascularity. Recognizing the complexity of the breast tissue, the breast
imaging community has shown an increasing interest in incorporating advanced DWI into their breast MRI
protocols27. However, expansion of advanced DWI to the breast has not been fully achieved28,29 due to two major
challenges. Firstly, commercial single-shot echo-planar imaging (ss-EPI) is prone to image distortion, which is
exacerbated in the breast due to off-center setting30–37. Secondly, an integrated approach with multiple MRI-
based metrics has not been established for breast tissue characterization38,39. The main goal of this project is
to develop two imaging tools to enable a comprehensive characterization of breast tissue: (1) a novel, distortion-
resilient, and time-efficient DWI acquisition technique, and (2) an integrated multi-modal MRI analysis framework.
Our overarching motivation is to bring the advancements in multi-high-b-value DWI to the breast.
The hypothesis is that breast neoplasm can be evaluated by characterizing tissue cellularity, vascularity,
and heterogeneity collectively; and these properties can be comprehensively probed by utilizing a set of DWI
parameters from the entire spectrum of b-values together with DCE-MRI metrics. The specific aims are:
1. To develop a novel, distortion-resilient, and time-efficient pulse sequence, Steer-PROP for breast DWI –
SPREAD – that will enable DWI with a full spectrum of b-values from 0 to 3000 s/mm2.
2. To establish MRI-based metrics for characterizing tissue cellularity, vascularity, and heterogeneity; and to
develop an integrated multi-modal MRI analysis framework – TERMINAL – for the breast.
3. To demonstrate a potential application of SPREAD and TERMINAL in the context of predicting response to
neoadjuvant chemotherapy (NAC) in breast cancer.
This project will provide novel tools to enable DWI acquisition with a full b-value spectrum and DWI
analysis for assessing malignancy and evaluating treatment response in breast cancer. Successful completion
of the project will serve as a prototype for the expansion of advanced DWI into breast imaging.

Public health relevance
PROJECT NARRATIVE This project aims to bring the advancements in multi-high-b-value diffusion-weighted imaging (DWI) to the breast to enable a comprehensive characterization of breast tissue. This will be achieved by developing a novel, distortion-resilient, and time-efficient diffusion pulse sequence – Steer-PROP for breast DWI (SPREAD) – and an integrated multi-modal MRI analysis framework – TERMINAL – for the breast. These important tools will enable DWI acquisition with a full b-value spectrum and DWI analysis for assessing malignancy and evaluating treatment response in breast cancer.